Temporal roles of Sonic and Indian Hedgehog in tunnel integration following anterior cruciate ligament reconstruction

Project Summary
This F31 fellowship application provides a training plan with a collaborative team in the McKay Orthopaedic
Research Labs at the University of Pennsylvania and an innovative research plan to prepare Mr. Timur
Kamalitdinov to be an independent scientist in the musculoskeletal field. Approximately 30% of adults in the
United States suffer from a musculoskeletal condition, with almost half of those conditions being tendon and
ligament injuries. These injuries often require repair (e.g., rotator cuff tendons) or reconstruction (e.g., anterior
cruciate ligament (ACL)) to re-integrate the tendon midsubstance with the underlying mineralized bone.
Recreating the zonal tendon-to-bone insertion site (i.e., enthesis) is critical for restoring normal tissue function.
Zonal enthesis formation involves anchoring collagen fibers, synthesizing proteoglycan-rich fibrocartilage, and
mineralizing this fibrocartilage. The Hedgehog (Hh) signaling pathway is a potent regulator of zonal tendon-to-
bone insertion formation during growth and development as it promotes the formation of the unmineralized and
mineralized fibrocartilage zones. Unfortunately, studying this pathway in traditional tendon-to-bone repair has
been challenging because these repair models do not sufficiently anchor collagen fibers to bone, much less
produce zones of fibrocartilage. Conversely, ligament reconstructions where a tendon graft is passed through
bone tunnels can produce zonal attachments in the tunnels. Therefore, we utilize innovative transgenic murine
ACL reconstruction models to elucidate the mechanisms of zonal tendon-to-bone attachment formation in order
to develop novel therapies to improve traditional tendon repair outcomes. Our preliminary data demonstrate that
Hh signaling promotes zonal tendon-to-bone integration following ACL reconstruction. The objective of this
proposal is to define the spatiotemporal roles of Sonic hedgehog (Shh) and Indian hedgehog (Ihh) in promoting
adult tendon-to-bone repair. Our hypothesis is that the Hh pathway plays a biphasic role during zonal tendon-to-
bone attachment formation following ACL reconstruction, with Shh acting in the early stages of repair to promote
expansion of the progenitor pool and Ihh facilitating fibrocartilage differentiation and maturation. We will use
multiplexed mineralized cryohistology and laser capture microdissection with microfluidic qPCR arrays to monitor
the zonal attachment formation and novel mechanical testing to assess tunnel integration strength. Targeting
specific ligands of the Hh pathway will provide key mechanistic insights into whether certain ligands are more
important during specific stages of the tunnel integration process, opening new avenues of research into novel
therapeutic targets to improve adult tendon-to-bone repair.

Public health relevance
Narrative Injuries to tendons and ligaments make up almost half of all musculoskeletal injuries yet the signaling pathways governing tissue formation during development and following injury remain poorly understood. These injuries often require repair procedures to reattach the soft tendon to the underlying mineralized bone, which often lead to disorganized scar instead of re-establishment of the zonal tendon-to-bone insertion site (i.e., enthesis). This proposal seeks to fill this knowledge gap by using a series of novel transgenic mouse models to elucidate the mechanistic roles of Hedgehog signaling ligands, potent regulators of zonal enthesis formation during growth and development, in different stages of the tendon-to-bone repair process following anterior cruciate ligament reconstruction.